ACCELERATE: Accelerating HSR at OSU

Project Summary
Our proposed T32 training program in health services research (HSR) at The Ohio State University (OSU),
“ACCELERATE: Accelerating HSR at OSU,” will prepare the next generation of researchers and clinician
researchers for careers in health services and health systems research. Each year we will recruit four
postdoctoral trainees from research and clinically oriented backgrounds to participate in our collaborative,
multidisciplinary training program. Our goal is to have a diverse pool of recruits who bring a wide range of
backgrounds and experiences to our program. Trainees will enroll in a two-year program designed to provide
individualized mentoring and training to prepare participants for independent careers as health services
researchers. Training elements will include a strong experiential component of health services and health
systems research content and methods alongside didactic instruction in relevant topics. Improving health equity
and increasing diversity and inclusion will be central themes throughout the program and related curriculum.
Together, trainee-mentorship teams will create individualized development plans focused on the trainee’s areas
of interest and career goals. Trainees will be expected to disseminate their research through publications and
presentations at national conferences, participate in the annual NRSA trainees research conference, and
prepare a competitive research proposal by the end of their program.
The ACCELERATE T32 Program will be led by a team of three experienced principal investigators who are
nationally recognized in health services and health systems research. Three additional co-investigators will
provide supplemental methodological and HSR content expertise. An Advisory Committee comprised of ten
senior HSR leaders from across OSU will provide strategic direction for program development and evaluation.
Unique aspects of ACCELERATE include being anchored in one of the most diverse colleges of medicine in the
country, capitalizing on the unparalleled depth and breadth of academic programs at OSU, focusing on
developing mentorship skills of junior faculty in partnership with experienced senior mentors to build the pipeline
of HSR mentors, and recruiting and training both non-clinician and clinician researchers to study and tackle the
myriad important challenges in HSR. Our goal is to train health services researchers to address the most
pressing issues in healthcare delivery, using data and innovative processes to help people increase their well-
being and access affordable, safe, and effective care throughout their lives.

Public health relevance
Project Narrative Our proposed T32 training program, “ACCELERATE: Accelerating HSR at OSU,” will prepare the next generation of researchers for careers in health services research. ACCELERATE will match experienced mentors with exceptional postdoctoral trainees in a collaborative, multidisciplinary environment at one of the most diverse colleges of medicine in the country. With a foundational emphasis on health equity, our trainees will be equipped to address the most pressing issues in the delivery of healthcare, using data and innovative processes to help people increase their well-being and access to affordable, safe, and effective care throughout their lives.